The Biology of Lung Metastasis in Breast Cancer

Metastasis is the major cause of mortality in human breast cancer. The mechanisms by which the primary tumor
microenvironment promotes the invasion and intravasation of tumor cells has been extensively studied. In
contrast, the mechanisms regulating extravasation of blood-borne tumor cells at distal sites, their
survival and proliferation in their new microenvironment, and their re-dissemination to additional sites,
are less studied and not well understood. Therefore, the investigation of the mechanisms that regulate
breast cancer cells at the metastatic site are an area of intense scientific interest with important clinical
applications.
CTCs efficiently disseminate throughout the body but form metastases with low frequency. The CTCs that
successfully extravasate, survive and grow at distal sites have acquired stem-like characteristics that promote
these processes. The acquisition of stem-like properties is closely linked to the epithelial-mesenchymal transition
(EMT). Thus, the transcriptional control of stemness and EMT is an important regulator of metastatic efficiency.
Stemness and/or EMT is induced by metabolic, hypoxic and redox stress, as well as by interactions with
macrophages and platelets. Understanding the regulation of tumor cell stemness by stromal cells could lead to
the identification of novel therapeutic targets for the treatment of metastatic disease.
Previous studies on the role of stemness in metastasis to distal sites has been significantly limited by the analytic
methods used. We have developed ground-breaking new techniques that allow us to directly interrogate the
relationship between stemness and the efficiency of extravasation, survival and growth in vivo. Our novel imaging
methods combine the use of a permanent lung imaging window compatible with multiphoton microscopy, novel
computational reconstructions of large fields of view, and newly developed biosensors that report on the
induction of stemness, hypoxia and ROS. These tools allow the visualization and analysis of breast cancer cells
as they extravasate and form metastatic colonies in the lung. In contrast, traditional end-point analyses of fixed
tissues cannot provide information on the role of stemness during extravasation and metastatic growth.
This Program Project is organized around three major questions. First, we will define the signaling pathways that
regulate breast cancer cells in the lung metastatic niche. Second, we will explore the induction of stem-like
properties in tumor cells by interactions with stromal cells, as a critical regulator of extravasation and subsequent
metastatic growth in the lung. Third, we will pursue novel preliminary data on the effects of chemotherapy in the
metastatic site. Taking advantage of important synergies between the Projects and innovative methodological
advances by the Cores, this PPG is well-positioned to make ground-breaking contributions to our understanding
of CTC extravasation and grow in the lung, as well as their re-disseminate to tertiary sites. These studies will
provide paradigm-shifting insights into the biology of metastasis, with important implications for the clinical
treatment of systemic metastatic disease in breast cancer.

Public health relevance
Metastasis is the major cause of mortality in human breast cancer. The mechanisms that allow tumor cells to move from the blood into the tissue at a distal site, survive and grow are of intense scientific and clinical interest. This Program Project will use novel methodologies to explore exciting new hypotheses about tumor cell behavior during the late steps of metastasis, and will have important implications for the clinical treatment of metastatic disease in breast cancer.